Enabling Anatomical, Functional, and Molecular Imaging by Upgrading a Vevo 3100 to Vevo F2-LAZR-X Ultrasound and Photoacoustic Scanner

PROJECT SUMMARY
The objective of this application is to furnish investigators from the University of Rochester, University of
Rochester Medical Center (URMC), and their collaborators with a state-of-the-art small animal imaging system,
the Vevo F2 LAZR-X. This advanced instrument, known as a high-resolution multi-model Ultrasound and
Photoacoustic Imaging System, offers the essential tools and resources to propel their interdisciplinary research
forward. With its ability to conduct real-time in-vivo imaging in rodents, the system can also be used to study
large animals. The University of Rochester boasts a robust portfolio of NIH-funded research programs and is the
hub for a large group of NIH-funded investigators conducting pioneering studies and translational research
across diverse research areas. These investigators represent many distinct departments associated with five
core research centers or institutes, guided by a nationally recognized research team specializing in ultrasound
and photoacoustic imaging.
Currently, despite a significant research demand for access to small animal imaging facilities, the University of
Rochester and URMC lacks a state-of-the-art photoacoustic imaging system for detailed anatomical, functional,
physiological, and molecular imaging. The aim of this application is to procure the Vevo F2 LAZR-X ultrasound
and photoacoustic imaging system that will enable investigators to undertake a wide spectrum of foundational
and applied research projects. The principal investigator and the key contributors seek not just enhancement of
new and ongoing research programs, but also to achieve greater understanding and appreciation of the
underpinning science and technology.
Introducing this distinctive and state of the art equipment to the University of Rochester will foster collaboration
among researchers who bring complementary methodologies to the table. This will bolster advancements in both
scientific and technological domains and enhance the development of our human resources. Acquiring and
maintaining state-of-the-art imaging methodologies attracts the best and brightest, produces sought-after
trainees with cutting edge training and marketable skills, and fosters the continuing success of our NIH-funded
programs across multiple disciplines.

Public health relevance
PROJECT NARRATIVE Harnessing the power of high-resolution, multi-modal acoustic imaging holds immense promise for exploring the intricate pathophysiological processes of human diseases using animal models. The Vevo F2 LAZR-X, a state- of-the-art preclinical imaging system that combines ultrasound (and ultrasound-based such as strain and Doppler) and photoacoustic modalities, emerges as the quintessential research platform for performing non-invasive, functional, and molecular methodologies in both small and large animal studies. By acquiring this advanced animal imager, we will substantially enhance the breadth and depth of multidisciplinary biomedical research efforts at the University of Rochester.